Intervention to Improve Driving Practices Among High-Risk Teen Drivers - Diversity Supplement Resubmission

Project Summary/Abstract
This document is not required for the supplement RFA since the abstract from the Parent R01 is
included in the Research Strategy section.

Public health relevance
Project Narrative This document is not required for the supplement RFA the Narrative from the Parent R01 remains the same.